ASYMMETRIC NEURODEGENERATION AND LANGUAGE IN PRIMARY PROGRESSIVE APHASIA

PROJECT SUMMARY / ABSTRACT
Primary Progressive Aphasia (PPA) is a dementia of language that emerges on a background of preserved
memory. It can be caused by multiple neuropathologic entities, including Alzheimer's disease (AD) and
frontotemporal lobar degenerations (FTLD). The one core feature of all PPA variants is the selective and
asymmetric neurodegeneration of the language-dominant (usually left) hemisphere. For the past 15 years, the
Northwestern PPA Program has enrolled patients for biennial cognitive evaluation, multimodal imaging, and
genetic characterization. Biofluids on all patients and brain tissue from those who have come to autopsy have
been banked, curated, and shared with the National Alzheimer's Coordinating Center (NACC) and the National
Centralized Repository for Alzheimer's Disease and Related Dementias (NCRAD). This cohort represents what
is arguably the world's largest registry of deeply phenotyped PPA patients. During the next cycle of this project,
PPA groups will be stratified by neuropathology rather than clinical variant. The three interactive specific aims
are to characterize neuropathology-specific fingerprints of asymmetry through multimodal imaging; to identify
neuropathology-specific correlates of neurosynaptic disruption, inflammatory markers, gene expression, and
their hemispheric asymmetry; and to explore molecular signatures of selective left hemisphere susceptibility
and memory resilience through genetic analyses. We will continue prospective enrollment into existing and
new projects and develop research methodology for single-subject rather than group studies so that individual
differences in brain organization can be taken into account. An overarching theme will be the clinicopathology
of asymmetry, which is the single universal core feature of PPA, and which offers a unique setting for
investigating the mechanisms of selective vulnerability. The innovative aspects include access to a uniformly
investigated unique PPA cohort, availability of autopsy tissue from both hemispheres so that asymmetry can
be quantitated, graph theory approaches to network architecture, genetic explorations of asymmetric
hemispheric vulnerability, and development of personalized single-subject mapping of the diseased language
network. The Northwestern PPA Research Program has made key contributions to research on the
neurobiology and cognitive characteristics of PPA by showing that the same syndrome (e.g., PPA) can be
caused by multiple neuropathologic entities, that a single disease (e.g., AD) can cause multiple syndromes,
and that clinical manifestations are determined by network anatomy rather than molecular pathology. Through
this work PPA has become a paradigmatic entity for establishing principles of pathophysiologic heterogeneity
in dementia. The aims in this proposal will help to shed additional light on the anatomical tropisms of
neurodegenerative diseases, the foundations of hemispheric asymmetry in neurodegeneration, the internal
architecture of the language network, and the mechanisms that mediate the resilience of memory function in
PPA with AD neuropathology.

Public health relevance
PROJECT NARRATIVE: Primary Progressive Aphasia (PPA) is a dementia that undermines word finding and the ability to communicate through the asymmetric degeneration of the language-dominant (usually left) hemisphere of the brain. It can be caused by multiple entities, including Alzheimer's disease (AD) and several forms of frontotemporal lobar degeneration (FTLD). This project, based on a unique group of longitudinally evaluated PPA participants, will explore disease-specific anatomic, cellular and molecular aspects of PPA so that each patient can be approached through principles of personalized medicine that address not only symptoms but also underlying disease types.